Mechanisms of Morphogen Transport and Interpretation in Early Embryos

PROJECT ABSTRACT
The long-term goal of this project is to understand how embryos accurately transmit instructions to their
constituent cells. This proposal focuses on signaling by Nodal, a model morphogen that induces endoderm and
mesoderm formation in early vertebrate embryos. Genetic and biochemical studies demonstrate that target
cells select fates based on their position a gradient of Nodal signaling activity. However, the mechanisms of
gradient formation and signal interpretation remain unclear. The proposed experiments will test competing
mechanisms for the spatial spread of signaling from an endogenous Nodal source (Aim 1), and explain how
similar signaling levels can specify more than one cell fate (Aim 2). These studies will be carried out in
zebrafish to take advantage of its unique genetic and optical tractability. This work will resolve controversies
concerning the role of diffusion in transporting endogenous Nodal ligands (K99), explore whether stochastic
noise in Nodal signaling influences germ layer specification in a vertebrate embryo (K99, R00) and identify new
Nodal-dependent gene expression programs (R00). Clarifying how Nodal signaling functions in vivo may also
have implications for medicine, as misregulation of Nodal signaling can drive birth defects and cancer in
humans. Finally, understanding the mechanisms that allow Nodal signals to transmit precise instructions will
inform tissue engineering and regenerative biology, as Nodal is used to control cell differentiation in vitro.
My career goal is to run an academic lab that studies how developing embryos achieve precise patterning in
the face of unexpected perturbations. The proposed experiments will give me the experience in embryology,
zebrafish genetics and optogenetics required for this goal. I have developed a detailed training plan with my
mentor, Dr. Alexander Schier, to help me transition to independence. I will meet regularly with Dr. Schier to
discuss research progress, strategies for grant writing, student mentorship and lab management. To practice
my mentorship skills, I will oversee the work of a graduate student. To broaden my scientific network, I will
present my work at two international meetings per year and participate in joint lab meetings with the Megason,
Zon and Ramanathan groups at Harvard. To seek out additional mentorship, I assembled a K99 advisory
committee consisting of Dr. Adam Cohen, Dr. Allon Klein, and Dr. Sean Megason. Their expertise in
optogenetics, single-cell transcriptomics and quantitative imaging will help me to execute my research plan on
the proposed schedule. As a member of the Harvard Department of Molecular and Cellular Biology, I will have
access to leaders in developmental biology, biophysics and genetics, as well as cutting-edge core facilities.
The Pathway to Independence Award will provide the time and freedom required to initiate an ambitious
research program on the mechanisms of robust patterning in developing embryos.

Public health relevance
PROJECT NARRATIVE Nodal signaling plays a crucial role in early embryonic development, and its misregulation can contribute to birth defects and cancer. This project will study how Nodal signaling gradients form in the early embryo, and how embryonic cells select fates based on Nodal signaling. This work will inform strategies for accurately controlling cell differentiation.